An Integrated Software Platform for Accelerating Image-Driven Ophthalmic Research and Driving New Insights and Endpoints to the Clinic

Project Summary
Translational Imaging Innovations (TII) is creating an integrated platform for the collection, curation, analysis
and sharing of ocular images and data. Our Integrated Translational Imaging™ platform integrates an electronic
research workflow management system with an image repository, or data lake, and provides methods for
controlling the flow of images and data to a visualization and image processing toolkit. We now address a specific
pain point within the Ophthalmology and Vision community: DICOM conformance. In 2021, the FDA officially
recognized DICOM as a consensus standard for Ophthalmic Image Management Systems, and the National Eye
Institute and American Academy of Ophthalmology issued a call to the ophthalmic device community to accelerate
adoption of DICOM. DICOM for ophthalmology consists of 12 separate standards. Building a DICOM image file
requires a) transforming a proprietary (or non-DICOM) image file into a DICOM image object, and b) populating
DICOM tags with metadata. DICOM specifies required tags and optional tags (even number tags per the standard)
and allows for non-standard proprietary tags (odd-numbered). Non-compliant image formats and proprietary tags
are widespread in ophthalmology, particularly in OCT. We therefore propose to build a DICOM image generator
into the TII ocuVault API and incorporate DICOM rendering into the TII image curation application, ocuLink.
The addition of DICOM reading and translation capabilities into ocuLink and ocuVault solves significant problems
for the ophthalmic research and development community. We provide an engine for providing control of the
images back to the owner. We apply a transparent, harmonized model that ensures that DICOM standard tools
can use .DCM files, while maintaining proprietary information where necessary. We apply the DICOM model to
image modalities where a DICOM supplement does not exist, accelerating the harmonization of new technologies
in constant development in ophthalmology.
Our AIMS are as follows: 1) Implement DICOM rendering into ocuLink; 2) Develop methods to translate proprietary
image formats to DICOM; 3) Develop an ocuVault – to – DICOM metadata mapping software utility; 4) Develop an
any – to – DICOM export method; 5) Develop DICOM-conformant metadata fill utility for files that do not have
embedded metadata; and 6) submit ocuLink and ocuVault for FDA 510(k) clearance as an Ophthalmic Imaging
Management Systems (FDA Product Code NFJ).
-1-

Public health relevance
Project Narrative With more than 20 million patients suffering from age-related macular degeneration, diabetic retinopathy, or glaucoma, it is crucial to develop non-invasive biomarkers as early predictors of eye disease and reliable tests of the safety and efficacy of new preventative and restorative therapies. Data standardization is critical to meet the unmet need for rapid access and analysis of ophthalmic research data for the discovery of these biomarkers. DICOM is a recognized standard for image exchange across healthcare, but adoption in ophthalmology is falling behind. We will integrate DICOM into the Translational Imaging Innovations ocular image management platform for direct application to DICOM-conformant images. We will also provide a DICOM translator for images that are not DICOM compliant to maximize the accessibility and interoperability of ophthalmic images for clinical research and clinical trials.